Biomarker and Imaging Core

Summary
The Imaging and Biomarker Core will facilitate the development and validation of promising biomarkers of
AD susceptibility, improve AD risk prediction, and identify promising directions for development of targeted
interventions. By creating this Yale ADRC Imaging and Biomarker Core, we leverage the vast experience of
Yale’s imaging and biomarker expertise to provide state-of-the-art acquisition and analysis of data and to focus
on the development of novel approaches to studying AD. The Imaging Component will i) provide imaging
protocols and data analysis strategies to facilitate in-vivo quantification of AD imaging biomarkers, ii) assess,
track and validate imaging biomarkers of AD neurobiology, and iii) correlate imaging findings with postmortem
neuropathological analysis and biofluid biomarkers, while the Biomarker Component will i) manage the Yale
ADRC Biospecimen Repository, ii) assess, track and validate biofluid and tissue biomarkers of AD, and iii)
develop and apply cutting-edge mass spectrometric approaches to identify and assess novel AD-associated
biomarkers.